Detecting pleiotropic effects through integration of omics data

Vast amounts of whole genome sequence and imputed sequence data are being generated for
many complex traits and diseases. Most studies, e.g. UK10K, National Heart, Lung and Blood
Institute-Exome Sequencing Project, have concentrated on detecting main effects. Pleiotropy,
although an important phenomenon in genetic etiology, has not been adequately studied and
methods are limited to detect pleiotropy for rare and imputed variants. Additionally, although
there have been reports of pleiotropic loci it has been difficult to elucidate if these effects
underlie disease etiology or are false positives. We will tackle this problem using a multi-prong
approach that utilizes pleiotropic association testing, estimating tissue-specific disease
heritability and detecting tissue-specific pleiotropy. To meet the goals of this study we will use
omics data, implement previously developed methods and extend existing methods to analyze
imputed and rare variants. To ensure discoveries for a large variety of complex diseases and
traits e.g. asthma, type 2 diabetes, adiposity, and lipids, and to demonstrate that these methods
are an effective approach to study pleiotropy, data from the UK Biobank (500,000 study
subjects) will be analyzed. A split sample design will be employed in which 350,000 subjects
(Release 2) for Discovery and 150,000 subjects (Release 1) for Replication. Secondary
replication and fine mapping will be performed using TOPMed data which will have >150,000
individuals with whole genome sequence data with 26% of these individuals being African-
American, 10% Hispanic, and 7% Asian. All methods will be implemented in our SEQSpark
software which uses parallel processing to make it feasible to analyze hundreds of thousands of
samples efficiently and quickly. Not only is this study expected to improve our understanding of
the genetic etiology for complex diseases and traits, but it also has high public health
significance; understanding pleiotropic effects will improve our ability to estimate genetic risk
and provide insight into drug targets for the development of treatments of multiple diseases due
to shared genetic architecture. The framework and software developed in this proposal will be
available to the scientific community to apply to other large datasets for the identification of
pleiotropic loci beyond those phenotypes described here.

Public health relevance
NARRATIVE Using omics data, we will elucidate pleiotropic variants that play a role in a number of common traits and diseases that have a high public health significance that include: asthma, adiposity, type 2 diabetes, and blood lipid profiles. We will accomplish these goals by using a large population sample of 500,000 individuals with genome-wide imputed sequence data, >150,000 subjects with whole genome sequence (WGS) data and ~950 subjects with gene expression data from 53 tissues and WGS data. We will use statistical methods to detect pleiotropic effects and perform biological validation in order to bring about a better understanding of the role pleiotropy plays in complex disease etiology.